The Role of B cells in the Origin and Progression of Multiple Sclerosis

PROJECT SUMMARY | 5R35NS111644 | Administrative Supplement
Multiple sclerosis (MS) is a chronic autoimmune disease of the central nervous system affecting nearly one
million individuals in the United States. The disease is characterized by acute and chronic inflammation, myelin
loss; oligodendrocyte, neuronal and axonal pathology; and progressive neurological dysfunction. A number of
breakthrough translational discoveries, and especially the highly beneficial effects of B cell depleting drugs, have
set the stage for a growing, yet still imperfect, therapeutic pipeline. Research will fall short of its potential to
improve patient outcomes until the trigger(s) of disease onset and modifiers of progression are identified.
Central to this project is the hypothesis that B cells presenting in the cerebrospinal fluid (CSF) and peripheral
blood during early MS play key roles in triggering MS and in mediating ongoing progressive disease activity. We
propose to interrogate unique patient cohorts, including an incident cohort, with novel enabling technologies to
identify triggers of MS and modifiers of the clinical course. Well characterized clinical populations followed
longitudinally over time, high-field serial magnetic resonance imaging (MRI), genetic information organized as
functional operational networks, and a focus on B cell biology are the central elements of this initiative. A primary
goal will be to characterize the molecular diversity of B cells and their receptors at various stages of disease to
identify pathogenic populations and their antigenic targets.
A multi-layered experimental strategy includes single cell B cell transcriptomics, together with comprehensive
phage-displayed synthetic human, viral and microbial peptidomes for the screening of antibody fingerprints
against external drivers in the serum, CSF, and recombinant antibody libraries. The integrative analysis will
contextualize the data using clinical, MRI and genetic determinants, striving to apply rigorous statistical
principles, including independent replication.

Public health relevance
PROJECT NARRATIVE | 5R35NS111644 | Administrative Supplement Multiple sclerosis is a common and disabling autoimmune disease of the central nervous system in which B cells play a central pathogenic role. The principal goal of the project is to identify the disease trigger(s), and to understand the mechanisms underlying disease progression. Central elements of this initiative include large well-characterized clinical populations, comprehensive biobanked materials, serial magnetic resonance imaging of the brain and spinal cord using novel quantitative techniques, complete genetic information, and state of the art tools to investigate B cell biology including single cell B cell transcriptomics, recombinant antibody libraries, and phage-displayed synthetic protein arrays to identify antibody reactivities against foreign and self proteins.